Admin Core

PROJECT SUMMARY/ABSTRACT
The overall goal of this application is to establish and characterize a large collection of minority patient-derived
cancer xenografts (PDXs) from two cancer types (gastric and lung) and utilize these PDXs to guide cancer
precision medicine decision making focusing on racial/ethnic minority populations. We established the University
of California and UT Southwestern Diversity-PDX and Trial Development Center (UCaTS) that is built on an
existing cancer health disparity research network, and includes six NCI-designated Comprehensive Cancer
Centers: UC Davis, UC Irvine Health Chao Family Comprehensive Cancer Center (UC Irvine), UC Los Angeles
Jonsson Comprehensive Cancer Center (UCLA), UC San Diego Moores Cancer Center, UC San Francisco
Helen Diller Family Comprehensive Cancer Center (UCSF) and University of Texas Southwestern Harold C.
Simmons Cancer Center (UTSW). The role of the Administrative Core is to coordinate the research effort among
different campuses and to maximize the use of the funding and resources. The Administrative core members
include UCaTS contact PI, who has conducted extensive research in PDXs and has national/international
leadership expertise in cancer health disparities. The contact PI, Dr. Carvajal-Carmona, will be responsible for
the overall program administration. Working closely with the contact PI, this Core will have support from a
Biostatistician, five Site PIs, and a UCD CRC to help coordinate patient specimen collection, the two Research
Project leads, and a grant administrator to operationalize UCaTS goals. The Administrative Core will maintain
constant contact with the NCI staff, the PDXNet Data Commons and Coordinating Center (PDCCC), Patient-
Derived Models Repository at Frederick National Laboratory for Cancer Research (PDMR-FNLCR), and other
PDX Development and Trials Centers (PDTCs) to develop standard operating procedures (SOPs), coordinate
research activities, cross-validate PDX research, and deposit PDX models into PDXNet. The Admin Core will be
responsible for establishing and maintaining Center communication and fiscal management to ensure UCaTS
will deliver its objectives in a timely manner.

Public health relevance
ADMINISTRATIVE CORE NARRATIVE The University of California and University of Texas Southwestern Diversity Patient-Derived Xenograft Development and Trial Center leverages the collective strengths of six NCI- Comprehensive Cancer Centers to create minority patient cancer models and characterize targeted treatment responses to stomach and lung tumors. The responsibility of the Administrative Core is to create an efficient infrastructure to a) coordinate specimen collection and data exchange, b) manage scientific progress and fiscal responsibilities, c) sustain quality assurance and quality control procedures, d) maintain communication with key stakeholders, and e) centralize standard operating procedures. Through UCaTS activities, we expect to extend our large repository to facilitate the discover of new therapies that could impact vulnerable racial and ethnic minority cancer patients.